Pittsburgh Undergraduate Research Diversity Program (PURDIP)

ABSTRACT
The goal of the Pittsburgh Undergraduate Research Diversity Program (PURDIP) is to catalyze the training and
career development of underrepresented minority undergraduate students in research, to enhance the diversity
of the biomedical, behavioral, and clinical research workforce in the mission areas of importance to the NHLBI.
This goal will be achieved through the provision of an intensive summer research educational experience in
innovative technologies and conceptual paradigms related to heart, lung, blood and sleep-related science at the
University of Pittsburgh. The focus of PURDIP is knowledge in Fundamentals of Biomedical and Behavioral
Research and Health Disparity, Mentored Research Projects and Learning Skills. Its objective is to help the
students discover their passion for research in heart, lung, sleep and blood science, provide hands-on research
experience to trainees to help them to better understand the biomedical, behavioral and clinical research
profession, and finally to motivate the trainees to continue on to graduate and other health professions careers.
Over 70 University of Pittsburgh academic faculty from the broad disciplines of cardiology, hematology/oncology,
vascular biology, molecular biology, pharmacology, coagulation and thrombosis, transfusion medicine,
regenerative medicine and sleep at the University of Pittsburgh are available to provide a broad array of basic,
behavioral, translational and clinical research topics and study patient populations to carry out this project. The
program is focused on multiple areas of heart, lung, blood and sleep research including hemolysis-related
vascular disorders, sickle cell disease, pulmonary hypertension, cardiac imaging, and cardiovascular health
outcomes. Training will incorporate the learning of cutting edge methodologies that is applied to a clinical
problem, leading to potentially novel therapeutic approaches or clinical studies in patients. Trainees will be paired
up with one clinical investigator and one basic or behavioral investigator to give them a broad perspective on
health-related research.

Public health relevance
NARRATIVE African Americans and Latino/Hispanic Americans have a higher risk of death from heart disease, and a disproportionally lower number of both minority groups are employed in the health professions and participate in clinical research. One approach to addressing these disparities is to increase the number of underrepresented minorities who pursue careers in the health professions. Thus, we will establish an intensive summer research education program to prepareand motivate underrepresented minority students to enroll in MD/PhD and PhD programs, building on the University of Pittsburgh’s track record in achieving success in such programs.